Biomaterial Scaffolds for Ex Vivo and In Situ CAR-T Cell Production

PROJECT SUMMARY
Despite unprecedented clinical success of chimeric antigen receptor (CAR)-T cell therapy against tumors,
widespread application is limited by lengthy and labor-intensive ex vivo manufacturing procedures that result in:
(i) very high costs of therapy of up to half of a million dollars; (ii) delays of weeks or months to infuse CAR-T cells
to patients with rapidly progressing disease; and (iii) heterogeneous composition and terminal differentiation of
infused CAR-T cells as a result of ex vivo culture that limit CAR-T cell engraftment and persistence. Despite
significant achievements in this space, reducing the time, costs and regulatory burden remains a deep unmet
need in CAR-T cell therapy and significant reducing or eliminating ex vivo procedures remains a critical unmet
need. The research outlined in this proposal develops new biomaterials approaches to reduce the time and effort
to produce CAR-T cells in vitro, to enhance CAR-T cell phenotype and function. We propose that a short (~hour)
pre-activation step with anti-CD3/CD28 antibodies can be immediately followed by transduction and delivery
using a biomaterial scaffold. This diversity supplement will support Dr. Trey Davis and allow him to participate in
new experiments to extend the scope of Aim 1 studies and will allow him to receive robust training in associated
techniques, professional development, and career planning. We expect that our results will provide a basis for a
general cellular therapeutic strategy and promote widespread patient access, especially to populations that have
been the victims of health disparities.

Public health relevance
RELEVANCE TO PUBLIC HEALTH CAR-T cell therapy drafts a patient’s immune system (cytotoxic T cells) to target and kill tumors and its combination of pin-point specificity and broad efficacy has translated into exciting clinical data and revolutionary treatment for certain blood cancers. The major impediment to widespread use of CAR-T therapy remains its cost, which approaches $500K, a slow manufacturing process and huge regulatory hurdles for facilities that manufacture CAR-T cells. We will develop biomaterial approaches to CAR-T cell therapy, including improved methods to reprogram cells, to release cells quickly to tumors, and even to generate the CAR-T cells entirely within a patient’s own body.